Deconstructing Post-Stroke Hemiparesis for Precision Neurorehabilitation

PROJECT SUMMARY / ABSTRACT
Dr. David Lin is a Neurocritical Care and Neurorehabilitation specialized Neurologist at VA Providence Health
Care System whose career goal is to conduct mechanistic clinical trials of neurorehabilitation technologies, to
maximize neuroplastic potential and functional recovery for Veterans with motor deficits after stroke. A critical
step towards this goal is for Dr. Lin to perform research and acquire training in the phenotype of upper extremity
stroke hemiparesis as well as its neuroanatomic and neurophysiologic underpinnings. Dr. Lin currently leads a
natural history study of upper extremity stroke motor recovery in which he has demonstrated the feasibility of
recruiting over 180 acute stroke patients with arm weakness into a research study and tracking their upper
extremity impairments from the acute to chronic stages of recovery. Dr. Lin is completing an analysis of patterns
of EEG cortical connectivity change after stroke in his VA CDA-1 project. In this Career Development Award-2
(CDA-2) project, Dr. Lin proposes to test specific systems neuroscience, model-driven hypothesis about the
relationship between the phenotype of post-stroke upper extremity hemiparesis with anatomy (assessed by
diffusion magnetic resonance imaging) and physiology (assessed by transcranial magnetic stimulation) of
specific descending motor pathways (corticospinal and corticoreticulospinal). Specifically, he will (1)
Deconstruct post-stroke hemiparesis into its individual components (2) Map descending motor tract anatomy
onto distinct components of post-stroke hemiparesis and (3) Map descending motor tract physiology onto
distinct components of post-stroke hemiparesis. To achieve these aims, Dr. Lin plans to conduct a new and
dedicated cross-sectional study at Providence VA of N = 75 Veterans with chronic hemiparesis after stroke.
The proposed CDA-2 project will provide Dr. Lin with fundamental training in motor control, structural
neuroimaging, motor systems neurophysiology, and applied biostatistics for neurorehabilitation research as
well as further experience with research skills necessary to lead an independent VA laboratory and clinical
trials. Dr. Lin will achieve the science and training proposed with the support of a world-class and
multidisciplinary mentorship team. Dr. Leigh Hochberg (primary mentor) and Dr. John Krakauer (primary co-
mentor) will coordinate a panel of content mentors (neuroimaging- Dr. Jennifer Barredo, neurophysiology- Dr.
Noah Philip, and kinematics and motor control - Dr. Steven Kautz) and subject advisors (neuroimaging- Dr.
Sanes, motor systems physiology- Dr. Monica Perez, neurotechnology- Dr. Karunesh Ganguly, applied
biostatistics- Dr. Jeff Goldsmith). Dr. Lin has developed a systematic mentoring and didactic plan to
complement the scientific activities in his proposed project. All of these activities will leverage the extensive
resources and world-class environment of VA RR&D Center for Neurorestoration and Neurotechnology (CfNN)
at Providence VA and research affiliate, Massachusetts General Hospital, Harvard Medical School. Thus, the
proposed VA patient-oriented research project, in concert with the mentorship and training plan, will provide
Dr. Lin with the scientific insights and skills that are essential for him to develop into an independent VA
physician-scientist career at the cutting edge of stroke neurorehabilitation and systems neuroscience.

Public health relevance
PROJECT NARRATIVE / RELEVANCE Improving stroke-related disability and stroke rehabilitation are major priorities for the VA healthcare system. Over 15,000 Veterans suffer from stroke each year in the United States, the majority of whom have resulting arm and hand motor impairments that limit their everyday function. Current treatment options to improve motor function after stroke are limited. Therapies including neurotechnological approaches (i.e. non-invasive brain stimulation and brain computer interfaces) for motor neurorehabilitation have not yet realized their potential to maximize recovery because the precise neuroanatomic and neurophysiologic mechanisms of upper extremity hemiparesis have not been clearly defined. Dr. Lin’s proposed career development plan has outstanding potential to advance knowledge about the neuroscientific mechanisms of upper extremity hemiparesis after stroke, which is a crucial step towards the development and translation of novel neurorehabilitation therapies to maximize functional recovery, improve stroke rehabilitation, and reduce stroke-related disability for Veterans.